Network of the National Library of Medicine Region 1

Overall Core Project Summary/Abstract
For over 35 years, the University of Maryland, Baltimore (UMB) Health Sciences & Human
Services Library (HS/HSL) has exemplified innovation, relevance, and far-reaching
advancement of equitable access to health information and data as the Regional Medical
Library (RML) of the Network of the National Library of Medicine (NNLM), Southeastern Atlantic
Region.
As the Region 1 RML for the 2021-2026 Cooperative Agreement, the RML Team proposes an
ambitious program that includes social justice, health and digital equity, environmental health,
and cultural humility topics in engagement, funding, and training opportunities for network
members. Done in tandem with responsive health, data and digital literacy programming the
RML Team expands the reach and impact of the National Library of Medicine (NLM) for all
populations and audiences and advances the mission of the NNLM.
The RML Team incorporates community-driven health outreach in the Region to bring quality
health, public health, cultural and environmental health, and biomedical information resources
and data within the easy to reach of the public, researchers, health professionals, public health
workforce, and educators, with an emphasis in developing a diverse workforce and reaching
underrepresented populations by:
• Cultivating synergistic partnerships within an inclusive governance and advisory structure for
Region 1 that advances the vision, strategies, and standards of NNLM.
• Developing a diverse workforce of trusted ambassadors to advance equitable access to
NLM biomedical health information resources and data-driven research to all audiences.
• Applying innovative, community-driven approaches and interventions to promote awareness
of, access to, and use of authoritative NLM resources and data sets to develop a diverse
workforce and reach underrepresented populations.
• Continually evaluating and improving the effectiveness, impact, and value of the RML
program to develop replicable outreach services and programs that are responsive to
measures of effectiveness.
Thinking nationally and acting regionally, the RML Team is eager to serve as the new Region 1
RML leading innovative initiatives in support of the development of a diverse workforce and
health and digital equity for all.

Public health relevance
Overall Core Project Narrative As the Region 1 RML for the 2021-2026 Cooperative Agreement, the University of Maryland, Baltimore (UMB) proposes an ambitious program that includes social justice, health and digital equity, environmental health, and cultural humility topics in all training, funding and engagement opportunities for NNLM members. Done in tandem with responsive health, data, and digital literacy programming, the reach and impact of the National Library of Medicine (NLM) expands for all populations and audiences and advances the mission of the Network of the National Library of Medicine (NNLM). Thinking nationally and acting regionally, the RML Team integrates the latest evidence-based research and replicable community-driven health outreach programs to improve health and digital equity, integrating principles of Diversity, Equity and Inclusion (DEI) in all activities.